ADOPTIVE TRANSFER OF MART-1 F5 TCR ENGINEERED PERIPHERAL BLOOD MONONUCLEAR CELLS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. In our approach we intend to deliver a MART-1 F5 TCR transgenic cell dose that will be one to two logs lower than the NCI protocol, and there is no experimental or clinical evidence of a decreased cell dose-related toxicity effect. Therefore, there is no need for a standard phase 1 dose escalation clinical trial design